Metabolic and neural activity normalization by cerebral blood flow increase in AD/ADRD models

SUMMARY
Although many biomarkers have been identified in AD/ADRD, the most important effect is cognitive function.
Links between AD/ADRD symptoms and cerebral blood flow deficits or vascular risk factors such as hypertension
are well recognized in patients, but the mechanisms are still under investigation. In mouse models of AD about
2% of capillaries are occluded by an arrested neutrophil and these stalled capillaries have a profound effect on
cerebral blood flow. Such capillary stall perfusion deficits (CSPD) could reduce oxygenation and nutrient delivery
to neurons and are therefore potential drivers of cognitive dysfunction in AD/ADRD. In AD mouse models,
working memory performance is rescued within hours of reducing the incidence of stalled capillaries to increase
cerebral blood flow using antibodies against the neutrophil protein Ly6G. CSPD has also been observed in a
new non-amyloid ADRD model, hypertensive mice with targeted replacement of the murine ApoE gene with the
AD-promoting ApoE4 human allele. In this mouse, rapid rescue of behavior and flow are observed after treatment
with the platelet inhibitor prasugrel, suggesting a different cellular cause of CSPD than that observed in the AD
models. The rapid time scales of cognitive recovery are too fast for many pathological processes and rule out
vascular or neural remodeling. Instead, the speed of memory improvement suggests that changes in the dynamic
firing pattern of neurons underlie the rescue and that improved metabolic support by increased cerebral blood
flow is a critical factor in determining the functionality of neural circuits. This suggests that slower processes such
as protein accumulation and remodeling can be secondary to fast effects linked to improvement of oxygen and
metabolite delivery after blood flow increase. This proposal tests the idea that cerebral blood flow recovery leads
to corrections in blood oxygenation and in oxygen usage, which then result in metabolic and cellular functional
recovery in neurons (Aim 1). Such metabolic changes are hypothesized to underly corrections of aberrant neural
activity that ultimately determine behavior. Aim 1 will use gamma oscillations, coordinated neural activity
associated with healthy cortical function, as a simultaneous measure of the consequence of the oxygenation
changes. In AD mouse models, an imbalance in the activity of inhibitory and excitatory neurons results in reduced
fidelity of neural encoding of stimuli. Aim 2 asks if the blood flow improvement also corrects this activity imbalance
and improves the precision of stimulus encoding for orientation tuned neurons in visual cortex. Aim 3 tests for
normalization of activity in hippocampal circuits involved in the formation and consolidation of memory, directly
testing the neural circuits involved in the memory tasks that CSPD reduction improves performance in. Age and
sex dependence of these phenomena are investigated in the APP/PS1 model of AD and this study also compares
to a new ApoE4-hypertension model and wild type animals with bead injections to mimic capillary stalls.
Understanding the mechanism of the rapid improvement in memory function after eliminating CSPD could lead
to future therapies that modulate the cognitive symptoms in AD/ADRDs.

Public health relevance
NARRATIVE Blood flow in brain of Alzheimer’s disease mice and patients is reduced relative to healthy counterparts. In Alzheimer’s disease mice, increasing brain blood flow leads to rapid improvements in memory performance. This grant examines the changes in brain tissue oxygenation, cellular metabolism, and neural activity that underlie improved performance on short term memory tasks observed after increasing cerebral blood flow.